Metabolic miR-137 Effects Contribute to Neuronal Signaling

Modified Project Summary/Abstract Section

Here, we focus on the microRNA, miR-137, which is enriched in the brain and strongly linked to Schizophrenia (SCZ) and Bipolar Disorder (BP) with genome-wide significance. In addition to neuropsychiatric symptoms, SCZ and BP patients suffer from ~10-15 year reduction in life expectancy and this early mortality is due to a high prevalence of obesity, Type II Diabetes (T2D), hyperglycemia, elevated cholesterol and triglycerides, high blood pressure, and irregularities in insulin signaling. Our overarching hypothesis is that miR-137 drives both neuronal and metabolic dysfunction, and that metabolic dysfunction contributes to disease susceptibility/progression. Drosophila has served as a powerful genetic model system for studying both neuronal signaling as well as obesity and diabetes because organs, signaling pathways and proteins, as well as neuronal ion channels/receptors are highly conserved across species, and many disease-associated genes are conserved between Drosophila and humans. Using Drosophila as an experimental system, we have found that miR-137 regulates both metabolic and neuronal function. In this application, we propose studies to further our understanding of how miR-137 affects metabolism to ultimately affect neuronal signaling.

Public health relevance
Modified Public Health Relevance Section Schizophrenia (SCZ) and Bipoloar Disorder (BP) are two of the most severe and debilitating mental disorders affecting more than 1% of the population. With complex etiologies and no cures, there is a need for a better understanding of underlying mechanisms of disease susceptibility and progression, which would likely reveal avenues for better treatment options. In addition to neuropsychiatric symptoms, SCZ and BP patients suffer from ~10-15 year reduction in life expectancy, and in both diseases, this early mortality is due to a high prevalence of obesity, Type II Diabetes (T2D), hyperglycemia, elevated cholesterol and triglycerides, high blood pressure, and irregularities in insulin signaling. Here, we focus on the microRNA, miR-137, which is enriched in the brain and strongly linked to SCZ and BP with genome-wide significance. Based on our preliminary and published data, we have found that miR-137 regulates both metabolic and neuronal function. We propose studies to further our understanding of how miR-137 affects metabolism and whether metabolic dysfunction contributes to neuronal dysfunction.